PHASE I TRIAL OF RP60475 ADMINISTERED AS A 1/2 HOUR INFUSION EVERY 21 DAYS

This is a phase I study to examine the antineoplastic effect of RP60475 (an inhibitor of topoisomerase) in patients with solid tumors who are refractory to all forms of standard therapy.